Consortium for Viral Systems Biology Technology Core

Project Summary / Abstract
Viral hemorrhagic fevers, of which Ebola virus (EBOV) and Lassa virus (LASV) are prototypical examples, are a
major source of human suﬀering. Recent outbreaks have raised concerns about the possibility of a global
outbreak. The ultimate goal of the Consortium for Viral Systems Biology (CViSB) is to deﬁne networks of host
and viral factors that drive clinical outcomes in Ebola virus disease (EVD) and Lassa fever (LF). The
responsibilities and contributions of the Technology Core fall into three main categories: data generation,
technology development and standardization, and evaluation and incorporation of emerging technologies.
Although these categories are distinct, they are tightly integrated. The Core’s role as data generation hub for
CViSB also mandates that we continually work to develop and improve our methods and to rapidly
incorporate novel technological advances to ensure that we remain a state-of-the-art, productive member of
the Center.
The Technology Core’s Aims are focused on the development, adaptation and standardization of innovative
experimental approaches in four main areas: (1) deep characterization of the adaptive immune response to
infection, (2) functional proﬁling of antiviral serum activity, (3) isolation and characterization of protective
monoclonal antibodies and (4) cost-eﬃcient viral genome sequencing. In addition to supporting the Center’s
Projects and contributing to the overall success of CViSB, the Technology Core will translate its technical and
methodological advances into standardized, reproducible protocols that will beneﬁt other Centers and the
broader infectious disease community.